Measuring treatment response and residual disease in leukemia with personalized, sensitive, and quantitative genomic methods

Project Summary / Abstract
N/A

Public health relevance
Project Narrative N/A